The role of protease activated receptor 2 in the initiation and progression of abdominal aortic aneurysm

ABSTRACT (Project Summary)
Rupture of abdominal aortic aneurysms (AAA) leads to sudden death in 15,000 to 30,000 men and women each
year in the US, and this number is growing due to both an increase in the elderly population and our increasingly
poor life-style choices, e.g. sedentary lifestyle and western diet, resulting in cardiovascular disease. Known risk
factors for AAA include tobacco use, hypertension, male gender, and cardiovascular disease. However, the
underlying cause of this condition is still poorly understood. Further, little progress has been made to identify any
pharmacologic treatments which may benefit these patients leaving surgery as the only treatment option. Here,
we define protease-activated receptor 2 (PAR2) as a novel mediator of aortic aneurysmal disease via potential
regulation of CD34+ progenitor cells. PAR2, a seven transmembrane G protein-coupled receptor, promotes
vascular inflammation via endothelial cell permeability, upregulation of cytokines, and vascular smooth muscle
cell (VSMC) and macrophage activation. Increased PAR2 expression and activity is associated with
cardiovascular diseases, known cardiovascular risk factors, and dysfunctional immunity. Our preliminary data
shows PAR2 deficiency attenuates aortic diameter, aneurysm incidence, and rupture-induced death in two
independent models of AAA via non-hematopoietic cells, with single cell RNA sequencing showing PAR2 highly
localized to the VSMC compartment of aneurysmal tissues. Moreover, activation of PAR2 results in the localized
release of transforming growth factor β1 (Tgfβ1) and decreased numbers of adventitial-derived CD34+ progenitor
cells leading to structural failure of the aortic wall. Our overall hypothesis is that VSMC-derived PAR2 augments
aneurysm pathology via decreased CD34-mediated myofibroblast tissue repair. Aim 1 of the grant will determine
the effect of VSMC-specific PAR2 deletion and pharmacological PAR2 inhibition in mouse models of aneurysmal
disease. Our second aim will delineate the role of PAR2 has in mediated CD34+ progenitor cells and their role
on the initiation and progression of AAA. Completion of these aims will advance our understanding of the role of
PAR2 and associate pathways on aneurysm initiation and progression and may lead to pharmaceutical
interventions where none currently exist.

Public health relevance
PROJECT NARRATIVE: RELEVANCE TO PUBLIC HEALTH Abdominal aortic aneurysm (AAA) is a vascular disease that affects 5-10% of men and 1% of women over the age of 65, ranking as the thirteenth leading cause of death in the United States. Unfortunately, there are no pharmacological treatments available for the prevention of AAA progression and rupture; the only option for these patients is surgical intervention. The purpose of this project is to examine the role of the multi-purpose protease-activated receptor 2 (PAR2) in the initiation and progression of aortic diseases in order to advance the field toward a viable medical pharmaceutical therapy.